Predicting complicated grief from grief processing

Abstract
Most people grieving the loss of a loved one will experience a period of intense pain and focusing on the loss
lasting around 6 months, which is known as acute grief. Complicated grief (CG) occurs when the experiences of
acute grief extend well past 6-months post-loss. Thoughts and feelings about the loss (i.e. grief processing)
occurring during acute grief may play a role in healthy grieving and protect against CG development.
Identification of the cognitive and emotional mechanisms of grief processing that contribute to healthy grief
resolution would advance knowledge of the goals of grieving and assist the development of interventions for
complicated grief. Two core components of grief processing are top-down regulation and balanced loss
confrontation. Top-down regulation is the ability to suppress processing of intrusive emotional information to
pursue a stated goal. Top-down regulation may facilitate healthy grieving by allowing reprieve from intense loss
related thinking. Balanced loss confrontation refers to the processing of the loss in a way that protects against
emotional overload. Confrontation with the loss may assist in the process of reforming one's mental
representations of the deceased. This study will test extrinsic and intrinsic measures of top-down regulation and
balanced loss confrontation during acute grieving as predictors of CG development a year later. We will recruit
a sample at high-risk for CG, the suicide-bereaved, in order to maximize the likeliness that a significant proportion
of the sample develops CG. The findings produced by this study may advance the knowledge of how CG
develops, assist in the identification of people at high-risk for developing CG and potentially form the basis for
targeted interventions.

Public health relevance
PROJECT NARRATIVE Complicated grief describes an inability to adjust to the loss of a loved one over the course of the first year following the death. This study will identify cognitive, emotional and neural processes occurring in the early grieving period (3 to 5-months post-loss) that predict or protect against the development of complicated grief a year later in suicide bereaved subjects, a sample at high-risk for developing complicated grief. These findings may advance understanding of the process of grief, facilitate early identification of high-risk grievers and potentially form the basis for targeted treatment of complicated grief.